Discovery of a High Affinity, Selective and β-arrestin Biased 5-HT7R Agonist

Project Summary/Abstract: The 5-hydroxytryptamine 7 receptor (5-HT7R) is a member of the G protein-
coupled 5-HT receptor family. Numerous studies have indicated that 5-HT7R plays a significant role in various
behavioral and psychophysiological functions such as mood stability, cognitive and motor functions, behavioral
inhibition, addictive behaviors, pain tolerance, sleep patterns, appetite, hormonal changes and thermoregulation.
Pre-clinical findings have established the role of 5-HT7R in autism spectrum disorders, Fragile X syndrome
(FXS), epilepsy, sleep disorders, neuropathic pain and migraine. Thus, 5-HT7R is emerging as a potential target
for the treatment of various psychiatric and other associated disorders. Meanwhile, several 5-HT7R agonists,
including AS-19, E-55888, LP-12, LP-44, LP-211, AGH-192 and compound 1g have been reported and their
potential use in various CNS conditions (pain, memory and cognition), neuropathic pain, sleep disorders,
alcohol and drug abuse are being investigated. However, the beneficial effects of activation or blockade of the
5-HT7R in each of these conditions is not often clearly established, primarily due to the lack of selective 5-
HT7R agents. Even more critical is the absence of biased ligands that could clarify several controversial
observations that relate to the 5-HT7R. Thus, our goal to design, synthesize and pharmacologically evaluate
new agents with biased signaling towards G-Protein or β-arrestin signaling pathways hold great promise in
understanding the 5-HT7R and its application to the treatment of various CNS disorders.
There are three specific aims proposed in this application. Specific aim 1 will focus on extending our
studies on the lead compounds (44080, 55933 and 57544) for their drug-like properties including brain
penetration, pharmacokinetic studies, metabolic profiling, bioavailability assessments and cardiovascular
toxicity predictions (HERG, 5-HT2BR). Based on the metabolic evaluations of lead compound 55933 from our
preliminary studies, the synthesis and screening of new compounds is proposed in specific aim 2. This specific
aim will also focus on the optimization and design of new agents to address the metabolic stability issues such
as aromatization and glucuronidation observed in the preliminary studies. For this reason, aromatization
susceptible tetrahydroisoquinoline (THI) moiety will be replaced with isoindoline which could not undergo
aromatization and the CH2OH group will be replaced with substituents such as -F, -CONH2 to restrict
glucuronidation while maintaining good drug-like characteristics. In addition, bioisosteric replacement of
indanone with dihydronaphthalenone (DNO) moiety will be carried out. Furthermore, exploring the electron
donating/withdrawing (σ values) and hydrophilic/hydrophobic (pi values) space around the THI/isoindoline
ring systems with substituents such as Cl, OMe, CN, SOCH3 and NMe2, will reveal any improvements in their
drug-like characteristics. Simultaneously, docking studies will be carried out using homology models to identify
interactions with the key amino acid residues involved in inducing conformations associated with β-arrestin
recruitment to the 5-HT7R. Specific Aim 3 will cover functional selectivity studies of lead 5-HT7R ligands for
their agonist/antagonist properties and G-Protein or β-arrestin signaling bias followed by evaluation of their
effect on sleep architecture and NREM/REM sleep pattern under in vivo conditions. Finally, selected test
compounds will be compared with SB269970 (5-HT7R antagonist) and compound 1g, a 5-HT7R partial agonist
(as a positive control) for their effect on NREM/REM sleep pattern and correlation of β-arrestin biased activity
using a mice model.

Public health relevance
Project Narrative According to the American Sleep Association, 50-70 million US adults have a sleep disorder, insomnia being the most common specific sleep disorder with 30% of adults reporting short term issues and 10% reporting chronic insomnia. Meanwhile, 37.9% US adults reported unintentionally falling asleep during the day at least once in the preceding month, while 4.7% reported nodding off or falling asleep while driving at least once in the preceding month. Given that drowsy driving is responsible for 1,550 fatalities and 40,000 nonfatal injuries annually in the US, this remains a serious public health crisis requiring serious attention. Meanwhile, neuropathic pain estimated in the general population to range between 3% and 17%, lacks an effective treatment as most of the available treatments have only moderate efficacy and present significant side effects that limit their use. Therefore, other therapeutic approaches, such as the development of biased 5- HT7R agonists which have been demonstrated to have therapeutic advantages for treating certain sleep disorders and neuropathic pain and are proposed in this application, are urgently needed.